Evaluation of a novel NLK function in lysosome biogenesis and neurodegenerative diseases

1R01AG074609-01
Janghoo Lim
In the majority of neurodegenerative diseases, including Alzheimer’s disease (AD), one or more proteins aggregate over the course of disease progression. In the case of amyotrophic lateral sclerosis (ALS) and frontotemporal dementia (FTD), AD, and other AD-related dementias (ADRDs), cytoplasmic inclusions of transactive response DNA binding protein 43 kDa (TDP-43) are observed in a large percentage of patients with sporadic and familial forms of disease. This aberrant accumulation of cytoplasmic TDP-43 is thought to underlie gain of toxic functions and exacerbate loss of nuclear function pathogenic mechanisms; therefore, preventing the formation or promoting the clearance of these inclusions may be an effective therapeutic approach for TDP-43 proteinopathies, such as AD and ADRDs. Currently, there are no therapeutics that effectively alter the course of most neurodegenerative diseases associated with TDP-43 proteinopathy. We have recently identified Nemo-like kinase (Nlk) as a negative regulator of the lysosome, a key organelle involved in cellular protein quality control that is capable of clearing toxic aggregated proteins. This proposal aims to better understand the basic molecular mechanism of Nlk’s regulation of lysosome gene expression in the nervous system and to test the modulatory effects of Nlk in ADRD animal models of TDP-43 aggregation. We propose the following three specific aims. Aim 1 will employ unbiased and targeted approaches to uncover fundamental mechanistic insights into the regulation of lysosome gene expression by Nlk in neurons. Aim 2 will determine which cell types mediate the function of Nlk in the regulation of the lysosome and TDP-43 proteinopathy in the nervous system in vivo using wild-type and TDP-43 animal models. Aim 3 will expand the scope of the proposed study to understand the therapeutic implications of Nlk reduction in animal models of TDP-43 aggregation through genetic and pharmacological reduction of Nlk levels at varying times in adulthood in vivo. In doing so, we will test the effect of Nlk reduction in the control of the onset and progression of pathological and motor behavioral changes in TDP-43 mouse models of ADRD. Aims 2 and 3 will provide critical proof-of-principle evidence regarding the effectiveness of lysosomal modulation in pre-clinical models of protein aggregation disorders. Together, this project will reveal novel molecules involved in lysosomal regulation in neurons that may be potential targets in the treatment of various neurodegenerative diseases, including AD and several AD-related disorders.

Public health relevance
The burden of frontotemporal dementia, amyotrophic lateral sclerosis, and other TDP- 43- related proteinopathies including Alzheimer’s disease is large, yet no effective therapeutics exist to effectively slow disease onset or progression. The studies outlined in this proposal will allow us to determine the molecular mechanisms underlying the regulation of lysosomal gene expression in neurons, and to rigorously test the therapeutic potential of a novel approach to increase lysosome biogenesis in animal models of TDP- 43 proteinopathy, which may eventually lead to the development of improved treatments for a range of neurodegenerative diseases in the future.